The Incidence and Etiology of Influenza-Associated Community-Acquired Pneumonia i

PROJECT SUMMARY / ABSTRACT Pneumonia remains the leading infectious cause of morbidity and mortality in the United States. In spite of its substantial public health burden, recent measurements of pneumonia incidence in the United States are surprisingly scarce and differences in research methodologies make the comparison of available estimates problematic. Moreover, our current knowledge of the distribution of etiologic organisms for community-acquired pneumonia (CAP) is limited and largely based on case series or studies performed decades ago or abroad. The availability of novel molecular techniques provides opportunities to reassess this knowledge systematically. Without current large-scale population-based studies to inform clinicians about the most likely etiologies of pneumonia and the identification of resistant organisms, clinicians would continue to assess and treat patients with pneumonia as they have for the past several decades. Since January 2010 we have conducted active population-based surveillance for pneumonia in subjects of all ages through the CDC-funded study, The incidence and etiology of influenza-associated pneumonia in hospitalized persons. The procedures for enrolling and testing eligible pneumonia patients have been well established; data collection forms have been developed and tested; CDC-endorsed laboratory procedures have been established; extensive data are now being collected and systematically entered into the master project databases; and radiographs from each pneumonia case are being evaluated by study radiologists. With these well established study methodologies and experience, we are well positioned to continue the CDC-funded pneumonia project for two additional years. We propose to use our existing infrastructure, skilled personnel, network capabilities, and previous experience to perform a multicenter, population-based, prospective cohort study to determine the incidence and etiologies of pneumonia leading to hospitalization for both children and adults. Our project encompasses the following specific aims: 1)To determine the incidence of hospitalization for community- acquired pneumonia in children and adults living in Middle Tennessee; 2) To determine the relative contributions of the different respiratory pathogens to the etiology of community-acquired pneumonia in children and adults hospitalized in Middle Tennessee; and, 3)To establish the burden of influenza associated with community-acquired pneumonia in children and adults hospitalized in Middle Tennessee.

Public health relevance
PROJECT NARRATIVE Contemporary, prospective, population-based studies on the burden of community-acquired pneumonia and its etiology are scarce; this information is critical to revising current treatment guidelines and for the efficient allocation of healthcare resources. We are currently conducting population-based surveillance of pneumonia hospitalizations for children and adults in middle Tennessee. We propose to continue the conduct of these studies to conclusively determine the burden and etiology of community-acquired pneumonia in the US for two more years. __SpecificAimsTextDelimiter__ SPECIFIC AIMS "The most widespread and fatal of all acute diseases, pneumonia, is now the Captain of the Men of Death" Sir William Osler, 19011 Pneumonia, together with influenza, remains the leading infectious cause of morbidity and mortality for children and adults in the United States, despite the advent of antimicrobial therapy and dramatic improvements in medical care. According to the Agency for Healthcare Research and Quality, nearly 1.2 million Americans were hospitalized for pneumonia in 2008 with associated healthcare costs estimated to be over $10 billion.2 In spite of this substantial public health burden attributable to pneumonia, recent measurements of pneumonia incidence in the United States are surprisingly scarce and differences in research methodologies make the comparison of available estimates problematic. Moreover, our current knowledge of the distribution of etiologic organisms for pneumonia is limited and largely based on case series or studies performed decades ago or abroad. The availability of novel molecular techniques provides opportunities to reassess this knowledge systematically. A number of efforts directed towards improving the health outcomes of patients with community-acquired pneumonia (CAP) rely upon knowing the microbial causes of pneumonia. Without current large-scale population studies to inform clinicians about the most likely etiologies of pneumonia and the identification of resistant organisms, clinicians must continue to assess and treat patients with pneumonia as they have for the past several decades. For the past ten years, we at Vanderbilt have successfully conducted prospective population-based surveillance for viral pathogens in young children with fever or acute respiratory illness in both hospital and outpatient settings as part of the CDC-funded New Vaccine Surveillance Network (NVSN). We have also conducted studies of influenza vaccine effectiveness through CDC-funded studies since 2008. Since January 2010 we have conducted active population-based surveillance for pneumonia in subjects of all ages through the CDC-funded study, "The incidence and etiology of influenza-associated pneumonia in hospitalized persons" project. The procedures for enrolling and testing eligible pneumonia patients have been well established, data collection forms have been developed and tested, CDC-endorsed laboratory procedures have been established and validated, study data are being collected and systematically entered into the project databases, and radiographs from each pneumonia case are being evaluated by study radiologists. With these well established study methodologies and experience, we are well positioned to continue the CDC-funded pneumonia project for two additional years. In this application we propose to use our existing infrastructure, skilled personnel, networks capabilities, and previous experience to perform a multicenter, population-based, prospective cohort study to determine the incidence and etiologies of CAP leading to hospitalization for children and adults in our region. Our project encompasses the following specific aims: 1. To determine the incidence of hospitalization for community-acquired pneumonia in children and adults living in Middle Tennessee. 2. To determine the relative contributions of the different respiratory pathogens to the etiology of community-acquired pneumonia in children and adults hospitalized in Middle Tennessee. 3. To establish the burden of influenza associated with community-acquired pneumonia in children and adults hospitalized in Middle Tennessee.